Determining the Role of SOX8 in Myogenesis and Rhabdomyosarcomagenesis

Project Summary/Abstract
Rhabdomyosarcoma (RMS) is a common aggressive pediatric soft tissue sarcoma. Despite many rigorous
clinical trials, the survival rate for high-risk patients has not increased in three decades. Furthermore, pediatric
RMS patients receive an aggressive combination of surgery, chemotherapy, and radiation, leading to life-long
treatment related consequences, underscoring the need to understand the basic biology of RMS to identify
new molecular targets. RMS is commonly viewed through the lens of muscle development where genetically
corrupted skeletal muscle progenitors fail to terminally differentiate. To understand RMS pathology, it is
essential to understand the role of RMS genes in normal myogenesis. To determine genes of interest, our lab
compared RMS core transcription factors (TFs), RMS essential genes, and genes overexpressed in our RMS
genetically-engineered-mouse-models (GEMMs) and identified three TFs were represented: Pax7, MyoD1,
and Sox8. PAX7 and MYOD1 play known roles in myogenesis and RMS, but the role of SOX8 in both
processes remains unclear. My proposed project focuses on determining the role of SOX8 in myogenesis and
rhabdomyosarcomagenesis. To determine the role of SOX8 in myogenesis I will perturb SOX8 in a primary
myoblast culture system as well as in vivo through our novel Sox8Flox mouse. Preliminary data shows that
SOX8 deficient myoblasts readily differentiate when not prompted, suggesting SOX8 is important for
maintaining muscle stem cell fate. I will analyze the ability of SOX8 deficient and over-expressing muscle stem
cells to pass through muscle differentiation to form functional muscle components. The second aspect of my
project is to identify the role of SOX8 in RMS. I will utilize human RMS cells and our RMS GEMMs to dissect
SOX8’s role in RMS tumorigenicity, tumor initiation, and transcriptional program through both loss-of-function
and gain-of-function experiments. Finally, I will determine the SOX8 interactome in human RMS cells to gain
mechanistic insight of SOX8 transcriptional regulation in human RMS. Understanding the role of SOX8 in
myogenesis and RMS will increase our understanding of myogenic cell corruption and reveal the potential for
core TFs to serve as therapeutic targets in RMS. St. Jude Children’s Research Hospital and the Hatley Lab
fully support my training goals and will support my training plans to learn scientific techniques for my project,
design rigorous and well-rounded experiments, scientific communication of my findings, and mentorship to
those around me. The Hatley Lab expertise in RMS, GEMMs, and molecular biology will aid in my training
goals. Additionally, the support garnered through the Core Facilities and Academic Programs Office at St. Jude
Children’s Research Hospital will further support my ability to perform the proposed experiments and
communicate the results effectively. The above combined with support from the Ruth L. Kirschtein Predoctoral
Individual National Research Award (F31) will provide an excellent launching pad for my career goal to
become an independent academic investigator.

Public health relevance
Project Narrative Rhabdomyosarcoma is the most common pediatric soft tissue sarcoma, and the survival rate has not increased for the past three decades. Our lab has shown that proteins called transcription factors can control the emergence and cell type of rhabdomyosarcoma through elegant mouse models. My project is specifically focused on understanding how the transcription factor SOX8 functions during normal muscle development and how rhabdomyosarcoma cells utilize SOX8 for tumor initiation and fate to potentially solidify a new therapeutic target for rhabdomyosarcoma.